Development of a protein therapeutics to counteract mustard-induced skin injury

PROJECT SUMMARY
Sulfur mustard (SM) and nitrogen mustard (NM) are vesicant agents that cause blistering of the skin. As
alkylating agents, SM/NM causes skin injuries through complicated cellular events, involving DNA damage, free
radical formation, and lipid peroxidation. Development of therapeutic approaches that target the multi-cellular
process of tissue injury-repair can potentially provide effective countermeasures to combat vesicant-induced
dermal lesions. Our group previously identified MG53 as an essential component of cell membrane repair.
Compared with the wild type mice, the mg53-/- mice show increased susceptibility to NM-induced dermal injuries,
whereas transgenic mice with overexpression of MG53 are resistant to dermal exposure of NM. Using live-cell
imaging, we made an unexpected and potentially exciting finding that in human follicle stem cells (HFSCs)
treated with NM, the intrinsic membrane repair function of MG53 was compromised. However, the application of
exogenous recombinant human MG53 (rhMG53) protein could restore cell membrane integrity from NM-induced
injury in both keratinocytes and HFSCs. We have generated preliminary data to show that topical administration
of rhMG53 can mitigate NM-induced dermal injury in mice. Studies proposed in this Exploratory and
Developmental R21 project are focused on understanding the mechanistic action of MG53 in skin wound repair
following NM exposure (Aim 1), and establishing the efficacious dose and effective time window for rhMG53
application to treat NM-induced skin injuries in mice (Aim 2). Pending on positive findings from this R21 project,
we plan to submit a larger CounterACT U01 application to further build the proof-of-concept data in large animal
models of SM-induced cutaneous injury, and to seek partnership with FDA and BARDA for advancing rhMG53
as a novel protein therapeutic that can be stockpiled as a medical reserve to treat cutaneous (and other organs)
injuries in the event of chemical warfare.

Public health relevance
PROJECT NARRATIVE Mustard exposure causes cutaneous toxicity and death. This project aims to develop a novel protein therapeutics to treat vesicant-induced cutaneous injury. The success of our study should advance our knowledge on the mechanisms of MG53 in skin protection associated with NM exposure, and help the development of novel therapies to counteract mustard-induced skin injury.